LYMPHOCYTIC ALVEOLITIS, INTERLEUKIN 1B AND LUNG INJURY

To assess the hypothesis that lymphocytic alveolitis is an important factor in the pulmonary damage associated with HIV infection, and that these effects are mediated by crucial alveolar lymphocyte-alveolar macrophage interactions.